BAFF-R CAR T cell therapy for ALL

PROJECT SUMMARY
B-cell acute lymphoblastic lymphoma (B-ALL) is a neoplasm of B-cell lymphoid precursors that typically affects
children, but occurs in adults as well. While intensive multi-agent chemotherapy is highly effective in the
pediatric population, outcomes remain poor in adults and high-risk patients. The recent introduction of
blinatumomab and CD19-directed CAR T therapy has transformed the care of patients with relapsed and
refractory (r/r) B-ALL. However, an increasing number of reports describe a high rate of post-treatment relapse
due to acquired resistance to these immunotherapies, notably via down-regulation or loss of CD19 surface
expression. CAR T cells that were recently developed against another target, CD22, showed similar
shortcomings with relapses associated with diminished antigen expression. The search for alternative targets
is therefore essential to overcoming antigen escape. To address this issue, we have developed CAR T cells
against a new B-ALL target, the B-cell activating factor receptor (BAFF-R). BAFF-R is a marker of B cells that
is also functionally expressed in B-ALL, including in patients with CD19-negative relapse. Although one of
BAFF-R’s ligands (BAFF) has been successfully targeted for the treatment of autoimmune diseases, we are
the first to have developed BAFF-R CAR T cells that are effective against B-cell malignancies in vivo, including
in CD19-negative mouse models. Because BAFF-R is a critical regulator of B-cell function and survival, we can
expect that the tumor’s ability to escape therapy by down-regulation of BAFF-R will be limited. While we
anticipate clinical efficacy of BAFF-R CAR T cell therapy, dual targeting of CD19 and BAFF-R can prevent the
emergence of resistance and improve clinical outcomes. Therefore, we are also developing bispecific CD19-
BAFF-R CAR T cells that we aim to rapidly translate from the bench to the bedside. In Specific Aim 1, we will
evaluate BAFF-R CAR T cell therapy in a first-in-human clinical trial in patients with r/r B-ALL who are ineligible
for or have failed prior CD19-directed therapy. The trial, currently open at City of Hope, will use our TN/MEM-
derived manufacturing platform, which yields a naïve/memory T-cell enriched T cell product and has shown
remarkable efficacy and tolerability in B-ALL. We will conduct extensive correlative studies using cutting-edge
technologies, such as assessing the kinetics of the CAR T cells and that of diverse cytokines, therapeutic
effect, and potential mechanisms of relapse and antigen escape. In Specific Aim 2, we will establish the
therapeutic efficacy of bispecific CD19-BAFF-R CAR T cells against mixed (CD19-negative + BAFF-R-
negative) B-ALL tumor models that mimic the heterogenous tumor phenotype leading to resistance. We will
also perform extensive testing of cGMP-grade bispecific CD19-BAFF-R CAR T cells that is required prior to
submission of an IND application to the FDA. Our proposal addresses the urgent need for new therapeutic
options in patients with r/r B-ALL and could also benefit patients with other B-cell malignancies.

Public health relevance
PROJECT NARRATIVE Nearly half of patients with B-cell acute lymphoblastic leukemia (B-ALL) who receive CD19-directed immunotherapy ultimately fail therapy, with down-regulation or loss of the CD19 target on B-ALL cells as a prominent cause of failure. To offer alternative treatment options to these patients, we have developed genetically-engineered human immune T cells targeting the B-cell activating factor receptor (BAFF-R) on B- ALL cells, and will conduct a first-in-human trial in patients who have failed prior CD19 therapy. To further improve patient outcomes, we are also developing bispecific T cells targeting both CD19 and BAFF-R to cut off tumor’s escape routes and prevent the re-emergence of malignant cells.